POSITRON TOMOGRAPH USING OPTICALLY COUPLED DETECTORS

We have previously demonstrated that a high-resolution positron emission tomograph can be constructed using six large-area position-sensitive sodium iodide (NaI(T1) scintillation detectors. The proposed research addresses a basic modification to the detection system which will result in significant performance improvements and a reduced system cost. Specifically, we propose to optically couple the system's detectors, enabling scintillation light to be shared by neighboring detectors. This eliminates the sharp boundaries between detectors, which will reduce the size of the effective gap between detectors, resulting in improved image quality. This should also permit us to substitute a reduced number of larger round photomultipliers for the current rectangular array of the more expensive square photomultipliers. Phase I of the project will investigate techniques for optically coupling the detectors, techniques for position estimation near the boundaries of two optically coupled detectors, and the adaptation of the event triggering system for use with optically-coupled detectors. Phase II of the project would concentrate on incorporating the optically coupled detector system into a tomograph.